Multiple long-term environmental exposures and incidence of asthma

ABSTRACT
Asthma is a disease of the respiratory tract that results in reversible narrowing of airways, leading to symptoms
ranging from wheezing and dyspnea to death. The US Centers for Disease Control estimate that over 26 million
Americans live with asthma. Incidence of asthma is more prevalent in boys in childhood, but is more prevalent
in women in adulthood, and there are wide disparities in asthma incidence by race/ethnicity, socioeconomic
status, and exposures to environmental factors. A growing body of evidence has suggested that individual
environmental exposures (e.g. air pollution) are associated with asthma incidence, however, other environmental
factors are understudied. Furthermore, most studies have only examined the health effects associated with one
environmental exposure at a time, or only in one stage of the life course (e.g. prenatal). In reality, individuals are
exposed to multiple exposures simultaneously. However, without rigorous approaches to estimate the health
effects associated with multiple exposures across decades, the environment-related health burden will likely be
underestimated, especially as these interconnections may be changing due to climate change.
Using the vast resources of the nationwide prospective Nurses’ Health Studies (NHS, NHSII, NHS3), Health
Professionals’ Follow-Up Study (HPFS) and the Growing Up Today Studies (GUTS), we are in a unique position
to study the complex associations of multiple long-term environmental exposures on incidence of asthma. GUTS
participants can be followed from the prenatal period through young adulthood, while all other cohorts can be
followed throughout adulthood. Using the addresses of each participant during follow-up, we are able to append
information on multiple chemical stressors (air pollution, traffic), physical stressors (temperature, humidity,
ultraviolet radiation), features of the built and natural environment (greenness, blue space, walkability) to more
than 300,000 participants for decades. Plasma metabolomics in adulthood are available for over 20,000
participants. These data will be used to explore biological pathways that may underlie the associations with the
environmental exposures. We will assess the following specific aims: (1) Determine how multiple long-term
environmental exposures are associated with incident asthma; (2) Identify demographic (e.g., age, sex,
race/ethnicity), behavioral, and social environmental characteristics that modify the associations of multiple
environmental exposures with incident asthma; (3) Explore how features of the plasma metabolome may mediate
the impact of the multiple environmental exposures in adulthood on incidence of asthma. Our findings will provide
valuable information on the role of modifiable exposures on risk of asthma, how multiple exposures interact, and
factors that impact resiliency.

Public health relevance
PROJECT NARRATIVE Asthma is a disease of the respiratory tract that results in the reversible narrowing of airways, leading to symptoms ranging from wheezing and trouble breathing to death, and it is estimated that over 26 million Americans live with asthma. A large body of evidence has suggested that individual environmental exposures (e.g. air pollution) in the short-term are associated with asthma exacerbations, however, other environmental factors are understudied and little is known about the effects of long-term exposures on asthma incidence as most studies have only examined the health effects associated with one lifestyle or environmental exposure at a time, although individuals are exposed to multiple exposures simultaneously. We will address these gaps using the unique resources of the nationwide prospective Nurses’ Health Studies (NHS, NHSII, NHS3), Health Professionals’ Follow-Up Study (HPFS) and the Growing Up Today Studies (GUTS).